DOUBLE-BLIND, PARALLEL GROUP COMPARISON OF LIBRAX AND ITS COMPONENTS IN PATIENTS

To compare the efficacy of Librax and placebo in irritable bowel syndrome patients in addition to assessing transit times.